Dissecting the Mechanisms of Quaking-Regulated RNA Processing

Abstract:
The overall goal of this research program is to determine how the Quaking-5 isoform (QKI5) of the QKI family of
RNA binding proteins regulates gene expression. To achieve this goal, we will determine how QKI5 is regulated,
how it executes regulatory functions, and what the consequences of these activities are on the overall gene
expression program. Pursuing this goal is the primary mission of my laboratory, and will be an engaging topic
upon which I will develop my lab and train post-docs and graduate students. QKI is a conserved regulator of
development and tissue-specific gene expression, yet the molecular mechanisms through which its functions are
executed remain understudied, particularly for the QKI5 isoform. Its importance is underscored by multiple
observations implicating dysregulated QKI function in heart disease, cancer, schizophrenia, and other serious
conditions, and our recent discovery that it regulates lineage-specific gene expression. Therefore, this RBP may
represent a therapeutic vulnerability for rational, RNA-based drug design, and inform us as to how the earliest
cell fate decisions are made. Despite this possibility, there are significant gaps in understanding that must be
filled prior to this becoming a reality. This requires us to illuminate the precise molecular mechanisms through
which individual target RNAs and the entire transcriptome are regulated. Hence, a major knowledge gap exists
in understanding the fundamental mechanisms used by QKI5 to execute its pre-mRNA splicing, transcript
localization, and stability/decay functions in RNA processing. This research program will leverage our molecular
genetics, biochemical, and genomics expertise to address key gaps in knowledge pertaining to this topic: 1) how
upstream regulation of QKI5 impacts its ability to regulate pre-mRNA splicing, and 2) how QKI5 directly and
indirectly regulates RNA splicing. Addressing these key gaps will tackle the upstream, intermediate, and
downstream impacts on, of, and by QKI regulation. We will use human and mouse cells, and cell extracts to
conduct these studies. We propose that QKI5 binding (and thus splicing activity) is influenced by a) competition
between pre-mRNA substrates and lncRNAs, and b) protein-protein interactions. Moreover, we propose that
regulated splicing by QKI5 is coupled to transcript localization and stability, and that QKI5 influences the core
spliceosome machinery. These studies will yield fundamental data that will inform the broader scientific
community as to how RBPs can be regulated and regulate gene expression. Overall, these findings will show
how complex, multi-step RNA processing is integrated into the overall flow of molecular information in order to
maintain cellular homeostasis.

Public health relevance
Dissecting the mechanisms of Quaking-regulated RNA processing Project Narrative: Gene expression controls nearly every biological process and is essential for life. The Quaking family of RNA binding proteins regulate diverse forms of RNA processing during development and their dysregulation can cause disease. This proposal will use the QKI5 isoform as a model RBP to dissect the fundamental regulatory mechanisms it uses to regulate RNA splicing, localization, and stability/decay to better understand how it influences global gene expression.